Mechanistic Insights into The Role of Microtubule Organizing Centers on Cardiomyocyte Structure and Function

Pediatric dilated cardiomyopathy (DCM) has a poor prognosis, particularly for infants <1-year-old, and the drug
development efforts have been hampered by the lack of understanding of disease pathophysiology. While the
majority of pediatric DCM cases are considered idiopathic, genetic etiologies are commonly suspected. Against
this backdrop, we recently identified the RTTN gene, encoding the centrosome protein Rotatin, as a new
causal gene for non-syndromic infantile dilated cardiomyopathy (iDCM). Additionally, we found that impaired
centrosome reduction, whereby certain centrosome proteins become “re-localized” to the perinuclear region to
form perinuclear microtubule organizing center (pnMTOC), underlies the structural and functional defects
observed in the mutant cardiomyocytes. While centrosome reduction has been associated with cell cycle exit
in the postnatal heart, this represents the first time in which the defective centrosome reduction/pnMTOC
assembly has been specifically linked to DCM in humans. Based on these findings we hypothesize that
RTTN is a key regulator of centrosome reduction/pnMTOC formation, required for the formation of
proper MT cytoskeleton that governs cardiomyocyte structure and function. To better understand the
composition and the functional role of pnMTOC important for proper sarcomere architecture during
cardiomyocyte maturation, we will utilize the following two specific aims: 1) Determine the centrosome-
associated constituents of the pnMTOC in cardiomyocytes and the mechanism that governs their perinuclear
localization during cardiac maturation. 2) Determine the mechanisms by which centrosome reduction and/or
pnMTOC governs cardiomyocyte structure and function. The proposed research is highly innovative in that it
leverages the newly discovered insights into iDCM pathogenesis to better understand the emerging role of the
centrosome as a key regulator of cardiomyocyte structure and function. In doing so, this study will define a
novel pathogenic mechanism for pediatric heart failure precipitated by impaired cardiomyocyte
maturation and open up new therapeutic opportunities for this devastating disease.

Public health relevance
We found that mutations in a centrosome protein rotatin (RTTN) cause infantile heart failure by disrupting the heart maturation program that normally occurs after birth. In this study, we will examine how RTTN regulates this process through a structure called the perinuclear microtubule organizing center (pnMTOC) and how this gene and others in the complex disrupt the sarcomere (the contractile unit) in cardiomyocytes. Our study will reveal how defects in certain centrosome proteins cause infantile heart failure and help develop new therapies for this devastating childhood illness.